Upper Midwest Summit for Reproductive Science

PROJECT SUMMARY
Reproductive health underpins overall health and thus research in reproductive science and medicine is
essential. This requires a steady pipeline of trained scientists and clinicians, which can be challenging given the
relatively small size of the field. Professional opportunities outside the laboratory and classroom are essential to
providing our trainees with important scientific, leadership, and career development experiences. Since 2008,
Northwestern and other institutions in Illinois, including the University of Illinois Urbana Champaign (UIUC), have
hosted a biannual meeting on a rotating basis entitled the Illinois Symposium for Reproductive Science (ISRS).
Given the strengths of our collective focus on reproductive science, our extensive trainee community, as well as
our established institutional infrastructures, our goal is to now expand this event to include five states and 16
institutions across the Upper Midwest region. This application seeks funds to support the Upper Midwest Summit
for Reproductive Science. This conference will be hosted by Northwestern and the University of Illinois Urbana
Champaign in alternate years. A hallmark of this event is that it is largely organized and coordinated by trainees,
providing valuable leadership and professional development experience. The trainee planning committee will be
responsible for identifying themes and speakers, hosting and chaperoning speakers, acting as session
moderators, and working the registration table. The event will be held over a period of a day and a half and will
consist of a variety of presentation formats. Dedicated poster sessions throughout the meeting allow participants
to present their research, receive constructive feedback, and engage in constructive dialogue other attendees.
Panel sessions and a career roundtable lunch will enhance the program by moving beyond the bench to discuss
topics such as innovation, advocacy, and communication. There will also be an invited keynote speaker, who will
be a luminary in the field, as well as an alumni speaker who will be someone who participated in the conference
as a trainee and now has a successful career in our discipline. Sessions will be organized by topics and invited
speakers and trainees will deliver oral presentations at this time. Throughout the conference there will be many
opportunities for trainees to network with each other and the conference will be an annual opportunity for trainees
to facilitate interaction among potential future lab mates, PIs, and collaborators. To further enhance the trainee
experience, both institutions have committed to provide funds for trainee research awards for outstanding oral
platforms and poster presentations. Together we will leverage our collective institutional strengths to maintain
the Upper Midwest Region as a preeminent nationwide leader in this critical research field.

Public health relevance
PROJECT RELEVANCE Reproductive science and medicine encompasses the study of endocrinology, gonad development, gametogenesis and embryogenesis, and reproductive tract biology and research in this area has implications for fertility, contraception, pregnancy, fetal origins of adult disease, transgenerational epigenetic inheritance, aging, cancers, infectious diseases, and more. This application will fund the Upper Midwest Summit for Reproductive Science (UMSRS), which will coalesce reproductive science and medicine research across 16 institutions in five states in the Upper Midwest region (Illinois, Indiana, Kentucky, Michigan, and Wisconsin). UMSRS will showcase cutting-edge research in our discipline and unify regional institutions to expand collaborative networks while providing trainees with valuable professional development and leadership opportunities.